BIO-ACTIVE COMPOUNDS VIA AQUEOUS ORGANIC CHEMISTRY

The objectives of the present proposal are (1) the total synthesis of the aglycone of tylosin, tylonolide, and (2) completion of the total synthesis of the ionophore A23187.